DNA Protein Cross-Links:Cellular Effects and Repair Mechanisms

DNA-protein cross-links (DPCs) are formed when proteins become covalently bound to DNA
form spontaneously as a result of normal cellular processes such as lipid peroxidation, histone
demethylation, DNA replication, transcription, and DNA repair. DPCs can be induced by
exposure to anti-tumor drugs, transition metals, UV light, and γ-radiation. DPCs interfere with
many biological processes and are implicated in the accelerated aging and increased cancer
incidence observed in Ruijs-Aalfs syndrome patients. The goal of our currently funded
application is to map DPC lesions along the genome, investigate how human cells recognize
and remove these exceedingly bulky DPC lesions, and to identify the mechanisms by which
they cause mutagenicity and cell death. The present supplement application with address the
potential involvement of DPCs in Alzheimer’s disease and other dementias. Our central
hypothesis is that that DNA-protein cross-linking induced by endogenous aldehydes and
environmental metals contribute to the etiology of AD and other age-related neurodegenerative
diseases. Our research plan focuses on two Aims. First, will characterize DNA-protein cross-
linking in brains of healthy individuals of increasing age, patients with mild cognitive decline,
Alzheimers’s disease patients, and nondemented elderly controls using novel mass
spectrometry based experimental methodologies already developed in our laboratory. These
studies will identify the proteins participating in DPC formation in human brain and test a
possible association of DNA-protein cross-linking with aging and neurodegenerative disease.
Second, we will identify the mechanisms of DPC formation in human brain but correlating DPC
levels in human brain to the concentrations of heavy metals, endogenous aldehydes, and
reactive oxygen species. These experiments will help identify the sources of DNA-protein cross-
links in human brain. Collectively, our proposed studies will facilitative future prevention and
treatment efforts by providing additional insight into the etiology of AD.

Public health relevance
Exposure to a wide variety of agents including occupational and environmental pollutants, anticancer drugs, and chemical species produced naturally as a result of cellular metabolism can cause proteins to become covalently attached to DNA. Failure to repair these DNA-protein cross-links can result in adverse outcomes including cell death and other age-related pathologies. The goals of this project are to understand how DNA protein crosslinks contribute to the development of Alzheimer’s disease and other age related dementias.